Development of pan- and phospho-specific nanobodies for investigating MAPK and PP2A signaling

PROJECT SUMMARY
The reversible phosphorylation of proteins is an essential process controlling cellular homeostasis. Protein
kinases catalyze the transfer of phosphate from ATP to tyrosine (Tyr), serine (Ser), and threonine (Thr) residues
in target proteins; protein phosphatases are responsible for removal of the phosphate group. Although Tyr
phosphorylation is far less abundant than Ser and Thr phosphorylation (<0.1% of the total cellular phospho-
amino acid content), it plays essential roles in many cellular signaling events. But Tyr phosphorylation is
especially difficult to study, because it is low abundance and functions in rapid signaling events with a lifetime
that is usually transient, increasing and then disappearing within minutes. Among the most useful tools for
examining protein phosphorylation are phospho-specific antibodies (Abs), which can be used to readily quantify
changes at phosphorylation sites and changes in their localization under various cell conditions. However,
reliable phospho-specific Abs are difficult to obtain, due to poor specificity, limited availability of large-scale
homogeneous preparations, and their inability to monitor protein phosphorylation in living cells. An attractive
alternative to Abs is nanobodies (Nbs) – small (15 kDa), single domain, antigen binding fragments derived from
camelid heavy chain-only Abs. Nbs targeting PTMs such as pTyr would be extremely valuable for the scientific
community but reports describing such are very scant or non-existent. Although it has proven to be difficult
developing Nbs targeting PTMs, our recent findings demonstrate remarkable success in developing Nbs
targeting specific pTyr epitopes in two important families of signaling proteins – protein phosphatase 2A (PP2A)
and the mitogen-activated protein kinase (MAPK) family member, ERK1/2. This proposal focuses on the
development, characterization, and application of Nbs recognizing specific phosphosites in different subunits of
PP2A, as well as the major MAPK family members, ERK1/2, JNK, and p38. We also will develop pan Nbs as
probes for total protein abundances. Our approach will characterize the binding specificity, recognition, and
affinity of each Nb for their targeted epitopes. We will determine the precise binding determinants by solving
atomic resolution structures of Nb-peptide and Nb-protein complexes. We will systematically test our Nbs for
their ability to recognize their respective phosphosite or protein target by Western analysis, immunoprecipitation,
and immunohistochemistry, and determine effects of Nbs on MAPK and PP2A activity. Finally, we will develop
Nb-based biosensors and PROTACs to respectively visualize phospho-epitope localization in cells and target
them for degradation in living cells. The proposed work is responsive to PA-22-127, a technology development
FOA requesting hypothesis-independent, broadly useful reagent and technology development. Completion of
the proposed studies will not only yield novel tools for investigating signaling enzymes, but it will also open the
door to a new technology that can be broadly applied to defining the phosphotyrosine proteome and expanding
knowledge about the functions of this essential protein signaling event.

Public health relevance
PROJECT NARRATIVE This proposal focuses on the development, characterization, and application of nanobodies (small antigen binding fragments derived from camelids) recognizing key phosphorylation sites on mitogen-activated protein kinases (MAPKs) and protein phosphatase 2A (PP2A) – two important families of signaling proteins that control cellular processes that drive cancer and other diseases. The proposed studies will not only yield novel tools for investigating MAPK and PP2A phosphorylation in both normal and pathological conditions, but also a new technology that will be broadly applicable for investigating protein phosphorylation events in many cellular signaling pathways.